DREF Research Matters: Creating Possibilities to Achieve Health and Wellness for All of Us Through Community and Researcher Engagement, Enrollment and Retention

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The purpose of the DREF Research Matters: Creating Possibilities to Achieve Health and Wellness for All of Us project is to help All of Us accelerate research advances and precision medicine. DREF will contribute to the building of the national research dataset by engaging with participants and educating adults, particularly parents of school-aged children, on the benefits of biomedical research and participation in clinical trials. These individuals will be encouraged to enroll in the program. DREF will also share information on the All of Us Research Hub and Researcher Workbench with researchers and encourage use of the dataset for multidisciplinary research projects.

Public health relevance
This project advances public health by educating communities about the All of Us Research Program and creating pathways for meaningful engagement, enrollment, and retention to support precision medicine research. By contributing to the development of a national research dataset and promoting use of the All of Us Research Hub and Researcher Workbench, the project helps accelerate multidisciplinary research and improve health outcomes for all populations.